KUH-TN Training Core

The TL1 Research Training Core (TL1 Core) of the Cleveland Kidney, Urology and Hematology Training Network
(KUH-TN) will provide a mentored research experience to predoctoral and postdoctoral trainees that will prepare
them for a research career as independently funded investigators, with a focus on the core mission areas of the
NIDDK: nephrology, benign urology and benign hematology (KUH). The cornerstone of the training is an
intensive mentored research experience with an accomplished basic or clinical science mentor(s) in one of the
KUH focus areas. This training experience is enriched with additional Core and Elective training components
organized through the Professional Development Core and implemented within the TL1 core. The additional
Core Training components are designed to ensure that each trainee receives in-depth instruction in the
pathophysiology of the trainee's primary KUH focus area (i.e. nephrology, benign urology or benign hematology)
as well as an introduction to the fundamental tools and skills broadly used in interdisciplinary and team science
(i.e. scientific writing, biostatistics, responsible conduct of research, leadership and laboratory management) and
an immersive clinical experience for trainees, who will not have this exposure through other training
mechanisms.. Trainees will also be introduced to innovative scientific methodologies and research strategies
through the KUH-TN biweekly seminar series organized by the Professional Development Core. The Elective
Training components provide a variety of supplemental training experiences, customized for each trainee, as
determined by the trainee and their mentor(s). Upon entering the program each trainee is assigned a Mentoring
Committee that will have formal meetings with the trainee every six months. The Mentoring Committee includes
a primary mentor, a professional development mentor and an additional committee member with related scientific
expertise. The role of the primary research mentor is to provide material support and guidance toward the
successful completion of all aspects of the mentored research project through weekly and ad hoc meetings. The
role of the Professional Development Mentor will be to meet with trainees quarterly to assess progress toward
career development and professional goals. The role of the additional committee member to provide additional
expertise and an objective assessment of the trainee's research and professional development progress at the
bi-annual committee meetings. Structured evaluation of Trainee's progress through the program is monitored by
a Program Evaluation Committee using and Individual Development Plan that captures the goals and
expectations of each trainees at the beginning of the year of training. The Program evaluation Committee will
also provide feedback to Training faculty mentoring trainees and tools to improve their mentoring style. Finally
The TL1 Core includes a Diversity and Recruitment Committee, whose role is to improve our engagement,
recruitment and retention in research and related careers of all our trainees, especially individuals from
underrepresented groups.
Project Summary/Abstract